The role of BHLHB2 in Scleroderma-Associated Lung Fibrosis

The Role of BHLHB2 in Scleroderma-Associated Lung Fibrosis
Scleroderma/Systemic Sclerosis (SSc) is a fibrosing multi-system rheumatic disease associated with excessive
deposition of extracellular matrix (ECM) components such as collagen and fibronectin. The predominant and
fatal complication of SSc is Pulmonary Fibrosis (PF), for which current treatments are marginally effective. IL-6
is a pro-inflammatory and pro-fibrotic cytokine produced in excess in SSc fibroblasts. Likewise, insulin-like growth
factor (IGF)-II, a member of the IGF family, is produced in excess in SSc fibroblasts and is implicated in the
development of pulmonary fibrosis. Our lab has shown that IGF-II levels are increased in both SSc lung tissues
and the primary fibroblasts derived from them, and that IGF-II induces a fibrotic response in normal lung (NL)
fibroblasts. IGF-II increases levels of collagen, fibronectin, and the pro-fibrotic transforming growth factor beta-2
(TGF2). In this application, we demonstrate that IL-6 increases IGF-II mRNA levels. Microarray analysis of
IGF-II-treated NL fibroblasts revealed increased expression of the Basic Helix-Loop-Helix transcription factor
family member, BHLHB2, a known regulator of the circadian rhythm, adipogenesis, and fibroblast autophagy.
Our preliminary data further show that both IL-6 and IGF-II increase nuclear BHLHB2 levels in NL fibroblasts.
We show that BHLHB2 activation is a common link between, and downstream mediator for several profibrotic
agents: TGF, IL-6 and IGF-II. Silencing BHLHB2 downregulated IGF-II. IGF-II induced BHLHB2 via signaling
through the Insulin Receptor. Thus, our central hypothesis is that BHLHB2 contributes to the progression of
Scleroderma-associated Lung Fibrosis by increasing levels of ECM genes. Our goal is to delineate the role of
BHLHB2 in the development of lung fibrosis in Systemic Sclerosis by (1) identifying the mechanism by which IL-
6 and IGF-II regulate BHLHB2, comparing differentially-expressed genes in single cell RNASeq of IGF-II-and IL-
6 stimulated normal lung and (2) elucidating the role of BHLHB2 in lung fibrosis. These aims are consistent with
the National Heart Lung and Blood Institute’s mission since they will provide important fundamental basis for
addressing translational aspects of the interaction between genetic dysregulation due to IGF-II and development
of SSc-associated PF. We envision that our work will provide a rationale for a therapy to block IL-6 and IGF-II
function concomitantly to halt the progression of lung fibrosis in SSc. Since SSc-PF is characterized by activation
of common fibrotic pathways and increases in ECM components (collagen, fibronectin), which are also increased
in different diseases characterized by lung fibrosis, our findings may have wider implications for lung fibrosis
associated with other diseases. In addition to facilitating a deeper understanding of mechanisms of SSc-PF, this
proposal provides Adegboyega Timothy Adewale with a rigorous training under the mentorship of Dr. Carol
Feghali-Bostwick and equips him with cutting-edge techniques to develop as an astute and skillful physician-
scientist.

Public health relevance
PROJECT NARRATIVE Systemic Sclerosis (SSc) is a chronic disease that causes impairment of gas exchange in the lungs, leading to respiratory failure. The aims and techniques described in this proposal are expected to answer the fundamental questions that will enhance the understanding of a potential mechanism that mediates lung fibrosis in SSc. Our findings will reveal new pathways by which BHLHB2 signaling perpetuates lung fibrosis and may lead to therapeutic strategies to block the progression of lung fibrosis in SSc.